Oklahoma Tribal, Rural, Urban Cancer Screening Trial ACCESS Hub

Project Summary/Abstract. The overarching goal for the Stephenson Cancer Center (SCC) Oklahoma Tribal,
Rural, Urban Cancer Screening Trial (OK TRUST) ACCESS Hub is to enhance capacity for increasing cancer
screening trials accrual and participation among tribal, rural and urban populations across Oklahoma. OK
TRUST is designed specifically to accrue large numbers of participants from these groups, as tribal, rural, and
low-income urban populations have disproportionately high cancer rates, but low rates of participation in
clinical trials at the national level. To increase clinical trial accessibility in rural locations, OK TRUST Affiliate
Organizations include a large, rural federally qualified health center (FQHC) with seven primary clinics, two
rural Tribes operating 10 tribal primary care clinics, and another rural Tribe closely associated with three Indian
Health Service clinics. As inaccessibility to clinical trials also affects low-income patients living in urban areas,
OK TRUST includes two large urban FQHCs located in Oklahoma City, one operating 21 clinics serving
predominately Spanish-speaking patients and the other operating 7 clinics serving many Black/African
American patients, and University of Oklahoma clinics in Oklahoma City and Tulsa that also serve large
numbers of Black/African American patients. OK Trust also includes the Oklahoma City Indian Clinic - the
largest urban Indian healthcare facility in the nation. In aggregate, 80,000 persons aged 45 to 70 years receive
healthcare at the OK TRUST Affiliate Organizations. Given the historical distrust between American Indian
communities and academic researchers and centers, it is notable that several Tribes and American Indian-
serving clinical facilities are participating in a project collecting biological data. These partners are involved
because they understand the impact that new cancer screening tests may have on reducing cancer disparities
among American Indian people. They also understand that a robust governance structure will guide use and
sharing of data involving American Indian participants, because Tribes, as sovereign nations, have rights that
are unique among underrepresented groups in the United States. Specifically, OK TRUST will implement
processes to: 1) Provide leadership and administrative support needed to conduct CSRN trials across tribal,
rural, and urban affiliate organizations in the Oklahoma catchment area and participate in shaping the CSRN
emerging research agenda. Provide leadership and administrative support to enhance the infrastructure
necessary to ensure Cancer Screening Research Network trial availability and participation across a diverse
set of tribal, rural, and urban Affiliate Organizations; 2) Expand access to and increase enrollment in cancer
screening trials by offering the Vanguard study, and future studies, in participants’ home communities and
healthcare facilities; and 3) Leverage SCC’s nationally recognized expertise in the provision of clinical trials to
include regulatory and operational support for cancer screening trials offered in tribal, rural and urban locations
statewide.

Public health relevance
Project Narrative. Cancer affects all populations, but some communities shoulder a heavier risk than others. In particular, persons from tribal, rural and urban inner-city communities face daunting challenges in accessing cancer screening and diagnostic follow-up services. The SCC Oklahoma TRUST ACCESS Hub will bring recent advances in cancer screening to high-risk tribal, rural and urban inner-city populations by increasing access to cutting-edge cancer screening trials.